SMII activity drives VSMC phenotype

ABSTRACT
Vascular smooth muscle cells (VSMCs) are highly dynamic and contractile, playing an essential role in the
physiologic regulation of blood flow. VSMCs exist on a functional spectrum between the physiologically
differentiated contractile phenotype and the pathological dedifferentiated migratory phenotype. Within a
lifetime, a single VSMC can transition back and forth along this phenotypic spectrum. VSMC migration is
necessary for tissue wound healing in response to vascular injury, facilitated by VSMC loss of contractility and
dedifferentiation. Misregulation of these transitions can be maladaptive, resulting in VSMC proliferation and
migration, and contributing to pathologies such as hypertension and atherosclerosis. There is limited
mechanistic knowledge of how the contractile machinery and its interplay with the mechanical environment
regulate the transition between phenotypes. Smooth muscle myosin II (SMII) plays an essential role in VSMC
contractility by assembling into bundles that bind and pull on the actin cytoskeleton. Our preliminary results
establish a discernible difference in endogenous EGFP-labeled SMII filament kinetics among varying
phenotypes of primary VSMCs. The dedifferentiated phenotype exhibits rapid SMII turnover while the
differentiated phenotype has stabilized SMII bundles that show little exchange of monomers. We hypothesize
that SMII-driven contractile activity is not simply correlated with VSMC phenotype, but that contractile activity is
determinant in establishing VSMC phenotype. To test this hypothesis, we will modulate contractility using
ex-vivo and hypertensive murine models, to investigate the role of SMII on VSMC phenotype in normal
physiology and pathophysiological contexts. In Aim I, we will characterize the role of SMII in the transitions
between phenotypes. We recently engineered a novel endogenously-tagged EGFP-SMII murine model, which
allows us to directly observe and quantify stepwise changes in both the expression and activity of VSMC
contractile machinery. By modulating SMII activity, we hypothesize we will be able to drive VSMCs from one
phenotype to the other. Our initial findings suggest that expression of pathology-associated SMII motor domain
variants in primary VSMCs results in an increase in filament exchange and a decrease in whole-cell
contractility, consistent with dedifferentiation. In Aim II, we will investigate SMII during VSMC phenotype
switching and vascular wall remodeling in vivo. Specifically, we will characterize the role of the entire cellular
contractile machinery during the progression from acute to chronic hypertension, using our EGFP-SMII murine
model with an angiotensin II infusion model of hypertension. By utilizing a novel EGFP-SMII murine model, we
plan to unveil the role of SMII in phenotype transitions in pathophysiology. We hypothesize that by modulating
SMII activity, we can drive VSMC phenotype.

Public health relevance
Project Narrative VSMCs make up the muscle layer of the artery wall, and through their contractile function, play an essential role in the regulation of blood flow. We aim to identify mechanisms by which the contractile machinery of these cells plays a role in pathological processes. We will use quantitative microscopy and innovative bioengineering techniques to study the impact of the contractile machinery on vascular cellular function.